REGIONAL BRAIN FUNCTION IN SCHIZOPHRENIA

The goal of projects is to study the neurobiology of schizophrenia through integration of clinical measures related to disease presentation and course with neurobehavioral, neuroanatomic and neurophysiologic parameters. A systematic examination of these measures in a longitudinal design will enhance the understanding of the pathophysiology of schizophrenia.